Bayesian Mortality Estimation from Disparate Data Sources

Project Summary: The goal of the proposal is to develop a Bayesian statistical framework for mortality estimation
from disparate data sources. Using this framework we will produce a suite of principled methods to be used in
those situations in which vital registration data are lacking. We will emphasize efﬁcient implementations that
can be used by researchers in low- and middle-income countries (LMICs), who may have limited computing
resources. In Aim 1, we will develop guidelines on a general statistical framework for mortality estimation. Aim 2
will focus on subnational child mortality with particular emphasis on the under-5 mortality rate (U5MR), which is
a key indicator of the health of a population, and the neonatal mortality rate (NMR). Excess mortality estimation
during the Covid-19 pandemic, by month, at the country level, will be the subject of Aim 3. We will disseminate
results widely and provide software and training in the developed methods.
We will produce yearly estimates of U5MR and NMR at the geographical level at which health decisions are
made. To achieve this goal, household survey, VR and census data must be combined in a coherent way. Census
data on child mortality typically provide summary birth history (SBH) data, which consist of mother's age along
with the number of children born and the number who died, but without the times at which those events occurred.
We will develop a framework for combining the different data sources, which will entail dealing with the design
issues in the household survey, accounting for unknown birth and death times in the SBH data, and estimating the
completeness of the VR data (births and deaths). We will also incorporate demographic information via a form
of Bayesian benchmarking. Effective and appropriate use of the models will require rigorous model assessment,
careful interpretation of results and meaningful and informative graphical summaries.
We will develop robust models to evaluate the excess mortality, i.e., the difference between the deaths ob-
served in the pandemic and those expected if the pandemic had not occurred. We will model the expected deaths,
and incorporate the uncertainty in this endeavor in the excess mortality calculation. Completeness of mortality
counts, that is, under-reporting and delays in reporting, will also be considered. For countries who do not report
deaths in the pandemic, we must predict the mortality count using available country-level covariate data, and we
will adopt ﬂexible yet interpretable regression forms, and acknowledge uncertainty in the covariate data.
We will produce user-friendly software for the methods, along with vignettes and training materials, including
short courses. The endpoint is to have software that can be used by researchers in LMICs. All aims will be
informed by the collaborative team's close links with the United Nations Inter-agency Group for Child Mortality
Estimation (for the subnational child mortality aim) and the World Health Organization Division of Data, Analytics
and Delivery for Impact (for the excess mortality aim). Together we will develop methods to highlight disparities
and inform interventions.

Public health relevance
Narrative: This project will develop methods for mortality estimation for countries that have limited reporting systems, with detailed models being produced for subnational child mortality and for excess mortality in the Covid-19 pandemic. With respect to child mortality, two key uses of the estimates are: (i) the assessment of whether Sustainable Development Goals (SDGs) are being attained, and (ii) identifying subnational areas that require public health interventions. For excess mortality, the estimates can be used to understand the space- time dynamics of the disease, and inform on the success of public health measures, so that the world is better prepared as the pandemic continues, or as new pandemics emerge.